Computational Design Engine for Accurate and Efficient Sequencing of DNA and RNA

PROJECT SUMMARY
The need to develop low-cost, rapid, and high-quality technologies for sequencing mammalian-
sized genomes has inspired many nanopore-based methods. All of these methods suffer from two
huge bottlenecks, which prohibit the required precision, and hence hinder the adoption of any of
these methods as a practical technology as of today. These bottlenecks are: (1) undesirable noise
levels for positioning DNA bases at read-out positions, and (2) difficulty in controlling capture
of large DNA molecules at the nanopore. By tackling these two critical challenges, we propose
to build a Computational Design Engine (CDE) to enable sequencing of DNA and RNA at the
maximum accuracy allowed by laws of physics.
The first aim is to reduce the positional noise of bases as DNA is being read. This goal will
be accomplished by innovative implementation of ideas based on stochastic resonance, ratchet
rectification, protein-assisted noise reduction, and non-enzymatic electrostatic traps. The proposed CDE will be able to design optimum features of AC fields, on top of ratcheting forces from enzymes and voltage gradients.
The second aim is to enhance capture of very large DNA and RNA molecules at the nanopore
for subsequent sequencing. The construction of the engine will incorporate all critical components
contributing to capture: entropic barriers, internal structures of RNA, entanglement effects of
DNA, electrostatics, electrohydrodynamics, and nanofluidics. The engine will design the best
experimental protocols, by optimum combinations of various contributing forces, to regulate the
capture efficiency of very large DNA and RNA.
For both aims, a broad suite of multi-scale modeling, and advanced theories of polymer physics
and non-equilibrium thermodynamics, will be used in innovative ways. The proposed CDE will put
theoretical bounds, based on sound laws of polymer physics, on sequencing accuracy in various
methods being pursued and how to attain their maximum capacities, and to designing better
alternative technologies.

Public health relevance
PROJECT NARRATIVE The proposed research is to build a robust Computational Design Engine as a key designing component in novel nucleic acid sequencing technology development. The construction of the engine will be based on sound laws of physics, incorporating various physicochemical concepts pertinent to sequencing of 150 kbp DNA and direct RNA sequencing. The Computational Design Engine will provide rational and innovative new designs for rapid and highest-accuracy sequencing of very large DNA and RNA.